Developing Future Scientists

Abstract
The Summer Undergraduate Research in Physiology (SURP) program at the University of Michigan,
currently funded by the R25HL108842 (“Promoting Diversity of Future Scientists”), is proposed to be extended
to another five incoming classes to provide training for underrepresented students to enter advanced graduate
programs or pursue careers in biomedical and clinical research. The renewal SURP program includes 23
excellent faculty mentors from basic science and clinical departments within the University of Michigan with
strong training record for undergraduate students. During the last funding period (2016-2023), we offered 80
summer fellowships to a total of 69 qualified underrepresented college students (6 of the 69 fellowships were
awarded to return students). All came from diverse and underserved backgrounds. Of the 44 graduated SURP
trainees whose whereabouts are known to us, 27 students are pursuing advanced trainings (PhD, MD, or MS),
7 participating in research (Research Assistants or Lab technicians), and 10 employed in STEM fields. Thus,
100% of our 44 graduated SURP trainees continued in graduate training, in research, or in science/technology
field, the kind of outcome our training program was aiming for. The focus of this renewal application is to
continue the successful SURP program by recruiting 10 students per summer. Our 12-week summer research
program includes (1) fulltime hands-on research experience in laboratories of our faculty mentors, (2)
mentoring meetings to ensure that student trainees are taking maximum advantages of all the resources
available to them; and (3) end of summer mini-symposium with oral presentations given by the students
sharing their research projects. The SURP educational program incorporates a noon lecture series, designed
specifically for the summer trainees and presented by faculty members, that teaches important physiology and
research related principles, including the use of different model organisms, ethics in laboratory research, and
career opportunities in biomedical sciences. We are fully committed to providing training to talented college
students, from currently underrepresented backgrounds, to meet the needs of an increasingly diverse
population.

Public health relevance
The goal of our renewal R25 program is to continue to provide undergraduate students from around the country an exciting research experience in cardiovascular, pulmonary or sleep-related physiology at the University of Michigan. Our goal is that this research experience will stimulate the career development of young talented students and promote interest in biomedical science careers.